ANCHR Research Core

PROJECT SUMMARY/ABSTRACT – Research Core
Understanding and addressing health disparities among Alaska Native (AN) people necessitates community
engaged health research based on careful study design, thoughtful analysis and interpretation, and proactive
knowledge dissemination and use. The Research Core of the Alaska Native Center for Health Research
(ANCHR) will leverage and coordinate institutional resources at the Alaska Native Tribal Health Consortium
(ANTHC) to provide critical health research services to Research Project Leads (RPLs) and Center
investigators who may lack the appropriate training, knowledge, or resources. The overarching goal of the
ANCHR Research Core is to increase ANTHC health research capacity by building an efficient hub of
research services to empower AN health research. The Core will accomplish this goal through several
specific aims. Specific Aim 1. Provide research design, biostatistics, bioethics, data acquisition and
management, and knowledge dissemination services for ANCHR research projects. The Core will
coordinate processes to oversee and deliver technical research support to RPLs. The Research Core will
work with individual investigators to co-design research support plans with deliverables that meet the needs
of each research project. Specific Aim 2. Promote, coordinate, and deliver the research services listed
in Aim 1 to institutional researchers, Tribal Health Organizations in Alaska, and other IDeA
institutions involved in AN health research. A Research Navigator employed by the Core will guide
internal and external investigators through tribal research processes and ethics oversight and connect
investigators to Core services and resources. The Research Core will prioritize research assistance to Tribal
Health Organizations (THOs) in Alaska conducting health research given the mission of ANTHC to “optimize
health and well-being through collaborative partnerships and services.” Research Core services will also be
made available to health researchers at other IDeA institutions in Alaska and nationally. Specific Aim 3.
Promote and advocate for community engaged research approaches that build on indigenous
knowledge, traditions, and strengths. The Research Core will promote best practices for community
engaged and community based participatory research by strengthening collaborations with regional THOs,
AN communities, and experts in community engagement. The Core will provide community engagement
support to RPLs, institutional researchers, and external researchers by leveraging internal and external
resources as appropriate to the specific research project. The Core will connect investigators with
indigenous research training program opportunities, promote research team inclusivity, and aid in the
dissemination of research results to tribal communities and other pertinent stakeholders.